Mouse Models Core D

MOUSE MODELS CORE D PROJECT SUMMARY
The objective of the Cleveland DDRCC Mouse Models Core is to provide a comprehensive set of cost-effective
services and shared resources to DDRCC investigators that augments their performance of in vivo studies
focused on the pathogenesis of Digestive Inflammation/Tumorigenesis and Liver Disease/Metabolism. The
overall goal of this Core is to provide centralized mouse modeling services that will enhance the pace of in vivo
digestive disease-related research at Case Western Reserve University and the Cleveland Clinic Lerner
Research Institute and provide communal, cost-effective access to unique mouse models on intestinal
inflammation and liver disease, thus resulting in new research projects, funding opportunities, and
collaborations in these areas of investigation. During the past funding cycle, the Core has been successful,
with an increase in the number of Core users and several important publications supported by the Core. The
Cleveland DDRCC Mouse Models Core achieves these goals through the following specific aims: (1) Provide
experimental cohorts of SAMP1/YitFc and TNFARE mice to Center members, other DDRCCs, and the US
scientific community; (2) Educate, consult, and train DDRCC investigators in the use of various mouse
modeling techniques; (3) Provide high-resolution murine video endoscopy with well-validated scoring of
intestinal inflammation and colonic tumors; (4) Quantify murine intestinal inflammation by 3-D
stereomicroscopy with assessment of myeloperoxidase activity; and (5) Interface with the Case Mouse
Metabolic Phenotyping Center to support DDRCC investigators performing murine metabolic studies and
provide joint educational programs on new technologies available for the study of murine inflammatory and
metabolic diseases. The DDRCC Mouse Models Core Steering Committee meets monthly to discuss
operational issues. The Core presents its operations to the DDRCC Executive Committee at their quarterly
meetings to evaluate the effectiveness of existing services against the evolving needs of the DDRCC
membership so that the Core brings the most benefit to the Center members and the scientific themes of the
Cleveland DDRCC. Thus, the Mouse Models Core benefits DDRCC members by providing a combination of
uniquely available resources and cost-effective services that facilitate the development of research related to
digestive diseases in the Cleveland scientific community and beyond.